A Community Built and Collaborative Research Education Program in Computational Neuroscience

Project Summary/Abstract
This project aims to provide accessible, national level education in computational neuroscience
in the form of a short-course research education experience. The purpose of this educational
experience is to supplement the training of a national workforce to provide them with new skills
and techniques relevant to the BRAIN Initiative. The BRAIN Initiative has brought about many
new tools and techniques as well as a vast quantity of data, but most neuroscientists are not
equipped to access, use, analyze, and integrate this data, so the focus of the proposed
educational activities are to enable the neuroscience workforce to handle this data while also
creating bridges for nearby disciplines, such as computer science, to contribute to neuroscience
research. To achieve the educational goals of the program, the proposed research education
program uses hands-on techniques in collaborative learning environments over a multi-week
intensive summer program. During this program experienced faculty and instructors help guide
small student learning groups through both instructional, interactive course materials and
mentored research projects in which students access actual BRAIN initiative data archives to
perform new analyses. By learning how to use BRAIN Initiative data, integrate it into realistic
models of the nervous system, and collaborate with others on its analysis and interpretation,
trainees of the program will be able to better understand the biological basis of mental
processes, behavior, and disorders. Overall, this national research education program in
computational techniques for neuroscience will help make researchers more effective, make
better use of BRAIN Initiative work up to this point, and accelerate our development of an
integrated understanding of the nervous system.

Public health relevance
Project Narrative The proposed project is a national, research education program that trains researchers on how to better utilize and understand the large quantity of neural data generated by the BRAIN Initiative. By empowering researchers to better access, use, and integrate this data, we accelerate our understanding and ability to model the nervous system as a whole. By better understanding and modeling the nervous system, we can better identify disorders and better predict therapeutic interventions for them.